Dynamic Haptic Robotic Training for Central Venous Catheter Insertion

Project Summary/Abstract
The goal of this project is to reduce the high mechanical and infectious complication rates of Central
Venous Catheter (CVC) placement through the development and implementation of enhanced training
methods; specifically, through the innovative concepts of Dynamic Haptic Robotic Training (DHRT) and the
advanced DHRT (DHRT+). Building on the progress of the PIs original R01 the proposed goal will be
accomplished through the completion of the three specific aims.
Specific Aim 1 Develop and implement whole procedure training through the integration of a
mixed reality smart tray, advanced testing surface, and high functional fidelity virtual
ultrasound imaging. In this aim, the novel concept of whole procedure training will be pursued, where
all 4 key steps of the CVC procedure are automatically trained. In addition optimized high fidelity real
time virtual ultrasound images will be developed through advanced modeling. The fidelity of these
advancements will be assessed through quantitative measurements and expert panel evaluation.
Specific Aim 2 Develop, implement, and evaluate the impact of adaptive feedback and
assessment on resident learning and surgical performance. In this aim, the development of optimal
performance metrics and assessment strategies will be investigated through expert and resident testing. In
addition the impact of the structure, type, components, and timing of adaptive feedback will be explored.
Specific Aim 3 Assess the wide-spread integration impact of the DHRT+ system on patient
outcomes and surgical performance through its incorporation into the residency curricula at
Hershey Medical Center (Hershey, PA) and Cedars-Sinai Medical Center (Los Angeles, CA). In
the final aim, long-term skill transfer and the impact of patient safety from DHRT and DHRT+ training will
be assessed. Specifically, 625 residents will be monitored as they progress through their first year at their
respective institutions, Hershey Medical Center and Cedars-Sinai Medical Center. The mechanical and
procedural complications they encounter on their first 5 supervised CVC procedures in the clinic will be
assessed. In addition, mechanical and infectious complication rates will be recorded for the residents' first
CVC patient.

Public health relevance
Project Narrative The goal of this study is to develop, implement, and explore the effectiveness of advanced dynamic haptic robotic training (DHRT+) for central venous catheterization (CVC) through a multi-institutional study with Cedars-Sinai Medical Center and Hershey Medical Center. The novel DHRT+ innovations allow for whole procedure training on a diversity of simulated patients, advanced adaptive feedback and assessment, and a global learning system which allows for communication between DHRT+ systems for the implementation of continual improvements. The proposed project will explore the effectiveness of training at reducing the high mechanical complications and infection rates that occur from CVC procedures.